DEVELOPMENT OF RAPID EFFECTIVE PROTEIN IDENTIFICATION ALGORITHMS "PROFOUND"

We have continued to refine a protein idenfication software routine called "ProFound", which makes use of information from mass spectrometric peptide maps to identify proteins whose sequence is stored in one of the publicly accessible databases. This program, which was written by Wenzhu Zhang (a member of our Research Resource) is publicly available over the World Wide Web (http//prowl-sgi.rockefeller.edu). The program is the only protein identification software currently available that uses robust probability criteria to rank the protein identification calls. In addition, it allows for the identification of mixtures of proteins using objective criteria. ProFound is being widely used by scientists all over the world. A paper describing the software is currently in preparation.